Career Enhancement Core-001

CAREER ENHANCEMENT CORE ABSTRACT
As part of a multifaceted approach to addressing disparities in cancer care, we must ensure that our
researchers are representative of the populations we serve. Because the population prevalence in Persistent
Poverty (PP) areas are from marginalized groups, our goal is to include investigators who are from
demographic groups that are traditionally underrepresented in medicine, such as persons who are Black/
African American, Hispanic/Latinx, from a low-income background, and/or identified as having a disability. The
goal of the Career Enhancement Core (CEC) is tailored to develop research capacity among early-stage, pre-
and post-doctoral researchers. As a career resource, guidance, and training hub of the proposed Center for
Cancer Control in Persistent Poverty Areas (C3P2), we will provide investigators with the resources and
experience to ready themselves for a competitive, independent career in cancer research, including critical
technical and scientific training, training in essential skills for scientific research, connections to experts for
collaboration and networking, and training in writing competitive grant applications to foster new projects. We
will also endeavor to provide a mechanism to harness the strengths of the University of Alabama at
Birmingham (UAB)'s Heersink School of Medicine, the UAB O'Neal Comprehensive Cancer Center, and the
UAB Minority Health & Health Disparities Research Center by offering opportunities for collaboration in team
science across the cancer continuum. The C3P2 CEC will be achieved by: 1) providing continuing education
opportunities, including workshops, skills enhancement courses, and seminars to assist early career
investigators in career development in cancer research among PP populations; 2) developing and sustaining
participation of a diverse cadre of early-career investigators in the activities of the C3P2, including research
and pilot projects and the larger Persistent Poverty Initiative Network (PPIN); and 3) providing mentoring and
career planning assistance to early-career investigators. Our previous experience and successful network of
mentoring and training programs make UAB uniquely situated to provide the expertise necessary to equip
early-stage investigators with the academic and experiential skills needed to achieve their career goals, while
developing personal relationships with participants to maintain their interest and investment.